Revealing Pathomechanisms of Mutant TPM1 Through a Hybrid Computational-Experimental Approach

PROJECT SUMMARY/ABSTRACT Revealing Pathomechanisms of Mutant TPM1 Through a Hybrid Computational-Experimental Approach The goal of this proposal is to develop and validate multiscale computational methods that can predict cardiac muscle behavior on the basis of genetic makeup. Single gene mutations have been identified as causative factors in a multitude of cardiovascular disorders, thanks to the emergence of genomic sequencing technologies. Genetic information has the power to transform clinical practice in many ways, but its potential remains unrealized because of major knowledge gaps in the chain of events linking mutations to observable disease states. Our goal is to unlock the rich molecular information that resides in known mutations by using new multiscale models that can predict molecular-scale phenomena and project them upward to scales of physiological relevance. We are poised to make key progress toward this goal thanks to an interdisciplinary team that includes experts in multiscale modeling, structural biology, biophysics, muscle mechanics, and stem cell biology. We will focus on tropomyosin (TPM1), a protein that regulates cardiac muscle contraction and which, when mutated, can lead to a life-threatening disease known as hypertrophic cardiomyopathy (HCM). At the cellular level, HCM involves abnormal cell growth due to increased expression of muscle proteins, but exactly how this overexpression is triggered by tropomyosin mutations is not known. In order to demonstrate that this type of genotype-phenotype gap can be closed by multiscale modeling, we will trace the effects of five tropomyosin mutations across molecular, sub-cellular, and cellular scales. In Aim 1, we will perform molecular dynamics simulations to predict changes in tropomyosin flexibility and actin surface interactions caused by mutations. Principles of statistical mechanics will be used to embed these changes within a model of the macromolecular actin filament complex. This scale-crossing technique will enable prediction of how mutations affect filament behavior in vitro. Companion experiments will test the model predictions. For Aim 2, the actin filament model will be placed within a representation of the cardiac sarcomere in order to predict dynamic muscle twitch responses for each mutant. These responses will be checked for accuracy by viral expression of mutant tropomyosins in human-derived engineered heart tissues. Aim 3 will use the models developed in Aims 1 & 2 to predict hypertrophic pathogenicity for 20 TPM1 variants identified in patients but never validated experimentally. Predictions will be checked by placing some of the analyzed variants into engineered heart tissues and measuring their hypertrophic responses. Feasibility of these aims is high because our team has the unique expertise required to relate the structural properties of mutant tropomyosins to their physiological behavior. In demonstrating a successful genotype-phenotype modeling approach, our work will pave the way for mechanistic investigation of many other cardiovascular disorders with genetic origins.

Public health relevance
PROJECT NARRATIVE Many gene mutations have been identified as causing cardiac diseases, but this information is of limited use without a detailed understanding of the mechanisms relating genotype and phenotype. As an example of how these types of gaps can be bridged, we will develop new multiscale models that predict the impact of tropomyosin (TPM1) mutations on cardiac cell hypertrophy. These predictions will be validated against experiments and refined to create a solid pattern for investigating other cardiovascular disorders with genetic origins.